Analysis of HSCR patient exome sequence data using Zebrafish

DESCRIPTION (provided by applicant): The goal of this project is to demonstrate that the zebrafish can be used to rapidly determine the functional significance of newly identified gene variants in Hirschsprung disease (HSCR) patients. HSCR is a pediatric condition where the enteric nervous system (ENS) fails to form properly. The disease occurs once in every 5,000 live births and occurs both familially and sparodically. HSCR is a classic multifactorial genetic disorder, and its genetic basis is only partly understood. So far, geneticists have identified 12 genes with mutations in HSCR patients. Of these genes, ret accounts for >80% of all known mutations. However the genetic basis of the disease in the vast majority of HSCR patients is unknown. Furthermore, there is a high degree of variability in the penetrance of the disease phenotype associated with mutations in the known HSCR genes. Recent studies have identified a ret susceptibility allele in an enhancer of intron 1 of the ret gene that appears to be a significant risk factor in developing the disease but it is not sufficient to cause HSCR on its own We have developed the zebrafish as a model system to study ENS development. We have shown there is a strong evolutionary conservation in the genes required for ENS development from zebrafish to man. Nearly all of the known HSCR genes have been shown to be required for normal zebrafish ENS development. Significantly, we have shown that antisense knockdown of the zebrafish orthologue of ret leads to intestinal aganglionosis in the fish. In this exploratory proposal, we will utilize the zebrafish model system to functionally analyze HSCR patients gene variants as a method to identify new causative HSCR genes. The proposed study is based on a long-standing collaboration between the Shepherd and Hofstra labs and utilizes the unique resources available to the labs (the collection of 400 Dutch HSCR patient DNA samples) and the expertise found in both the Shepherd (Zebrafish ENS development) and Hofstra (Genetic basis of HSCR) labs. Aim1: Identify gene variants in HSCR patients. There is a need for gene discovery in HSCR patients whose disease is currently not assigned to a specific gene or genes. We will perform exome sequencing on a selected group of HSCR patients who have the highest probability of having a strong loss of function coding mutation in one or more genes not previously implicated in the disease. Aim 2: Assess the functional significance of 10 selected HSCR exome identified genes in zebrafish. We will clone and characterize the expression of zebrafish orthologues of the HSCR variant genes. We will then use anti-sense oligonucleotides to assess the effects of these genes on zebrafish ENS development either alone or in combination with ret mutations in order to test for epistasis. The proposed Aims will identify new genes or gene combinations that cause HSCR. This will benefit patients directly when they undergo genetic screening for the condition and will potentially offer scientists new targets for the development of novel therapies to treat HSCR.

Public health relevance
PUBLIC HEALTH RELEVANCE: The genetic basis of the common human pediatric disease, Hirschsprung's disease, is only partly understood. Children with this disease fail to develop a normal intestinal nervous system. We propose to identify new genes that potentially underlie this condition and determine their functional significance in intestinal nervous system development using the zebrafish model system.